Bridge to the Doctorate at UMET: Building the next gene*

DESCRIPTION (provided by the applicant): The Bridge to the Doctorate at UMET project aims to contribute to build the next generation of minority scientists in environmental biomedical sciences, with a higher expertise to study the environmental factors that influence the well being and health of the general community, and the necessary skills to deliver scientific understanding to their communities. The project will establish a support network between the School of Environmental Affairs (SEA) at Universidad Metropolitana (UMET) and the School of Public Health at University of North Carolina at Chapel Hill (UNC) to promote the transition of master's degree level students to doctoral (Ph.D.) level in the area of bio - environmental sciences increasing the number of minority scientists in environmental biomedical research. Students will participate in seminars and workshops in responsible research conduct, ethics, and policies. The project will expose students to a potential network of local scientists that can serve as role models in their biomedical careers. In addition, students will receive training in strategies and skills to achieve scores in the graduate school examination tests (GRE and TOEFL) that will allow them to enter the doctoral (Ph.D.) program in environmental sciences and engineering at UNC. The project will implement an in situ research summer experience at UNC for four (4) selected UMET SEA students with the potential to transfer to the doctoral (Ph.D.) program. The project will provide funds to student research (research salary, materials, and supplies) for the summer experiences and to complete the research for the master's degree thesis dissertation. It is expected that a total of 12 students transition, continue and obtained Ph. D. degrees in Environmental Sciences and Engineering at UNC. Also, it is expected that at least 30 students participate of each the six (6) student development activities sponsored by the project event for a yearly total of 180 students. Thus, for the duration of the project a grand total of 540 students will benefit from these development activities and will learn more about graduate studies in biomedical sciences.